Indole Alkaloids and Phenazine Antibiotics: New Platforms for Drug Discovery

Indole Alkaloids and Phenazine Antibiotics: New Platforms For Drug Discovery
Abstract:
New small molecule probes and therapeutic agents are critical for the study and treatment of human
disease. Our group is developing multiple chemical synthesis strategies to probe diverse biological
phenomena related to human disease, including: bacterial biofilm viability, GPCR function, cancer
biology and Plasmodium falciparum biology. We have developed a tryptoline-based ring distortion
strategy using commercially available indole alkaloids (yohimbine and vincamine) as starting points for
ring distortion, or the dramatic altering/reorganization of complex ring systems using chemoselective
reactions. This approach has enabled the rapid synthesis of highly complex and diverse scaffolds for
biological investigations and we have identified hit compounds in multiple disease-relevant areas
pertinent to human health. Our hit compounds have gained new biological functions as their biological
activities are unrelated to other scaffolds or their parent natural product, in essence, re-engineering of
indole alkaloid’s chemical scaffolds and biological functions have been demonstrated. During this award,
we will enhance the chemical diversity of our indole alkaloid ring distortion library by using C-H oxidation
chemistry to install new synthetic handles for ring distortion and diastereoselective oxidative
rearrangements to give new spirooxindole scaffolds with the ultimate goal of exploring disease-relevant
chemical space with our probe molecules. In addition, our group has identified a series of halogenated
phenazines (HP) that demonstrate potent biofilm-eradicating activities. These findings are significant as
bacterial biofilms, or surface-attached bacterial communities, house persistent, non-replicating bacteria
(persister cells) that demonstrate tolerance to all classes of antibiotics. Biofilms pose a significant threat
to human health as 17 million new biofilm-associated bacterial infections occur annually that result in
550,000 deaths in the United States. We aim to use the HP small molecules we have developed as
probe molecules in RNA-seq experiments with MRSA biofilms alongside other biofilm-killing agents to
investigate biofilm viability with the goal of identifying new targets and cellular pathways critical to
bacterial biofilms. In addition, we aim to develop a diverse array of HP prodrugs through chemical
synthesis and in vitro biological studies. Providing new insights into the basic biology critical to biofilm
cell viability and developing new biofilm-eradicating prodrugs could lead to ground-breaking cures for
persistent bacterial infections.
Huigens (PI) Project Summary/Abstract

Public health relevance
Public Health Relevance Statement: New small molecule probes and therapeutic agents are critical for the study and treatment of human disease. Our group is developing multiple chemical synthesis strategies to probe diverse biological phenomena related to human disease, including: bacterial biofilm viability, GPCR function, cancer biology and Plasmodium falciparum biology. In the first strategy, our lab is developing an innovative tryptoline ring distortion approach to rapidly generate complex and diverse compounds from available indole alkaloids. In preliminary studies, we have demonstrated this approach to generate an array of compounds that have various biological activities, which will be used to explore the basic biology of cancer, GPCRs and P. falciparum. In our second chemical synthesis strategy, we are developing new bacterial selective halogenated phenazine prodrugs that can eradicate surface-attached bacterial biofilms, which lead to persistent and recurring bacterial infections. In addition, we are utilizing RNA- seq and a diverse panel of biofilm-eradicating agents as a chemical biology platform to investigate the basic biology of biofilm viability. Huigens (PI) Public Health Relevance Statement/Project Narrative